Indigo Eyewear for Treating Myopia Progression

Project Summary/Abstract
Myopia is the most common eye condition worldwide, where distant objects appear blurry. Typically, myopia
develops during childhood/adolescence but increases the risk of developing vision-threatening conditions,
including macular degeneration, retinal detachment, and glaucoma later in life. Furthermore, uncorrected
distance refractive error has been estimated to result in a global loss of productivity of $202 billion annually. The
rapid increase in myopia prevalence also known as the “Myopia Boom” is alarming, but existing treatments are
only partially effective or induce significant adverse effects. We have discovered that indigo light can completely
suppress a strong myopiagenic stimulus in a near-primate model. Based on extensive preclinical research, we
have identified the most effective indigo wavelengths for the suppression of myopia. Importantly, our discovery
is consistent with the environmental origin of the Myopia Boom, where sunlight, with its abundant indigo photons,
is protective and time spent indoors, where indigo photons are mostly absent, is a risk factor. Based on this
discovery, we propose a new modality for the treatment of myopia progression in children and adolescents:
indigo light emitting eyewear. This is an exciting treatment strategy because it may enable a highly effective,
safe, noninvasive, simple to use, and cost-effective treatment for childhood myopia. In this Phase I project, we
propose (i) to advance technical merit by developing a new prototype for low volume production and formal
safety evaluation; and (ii) to evaluate feasibility by performing a pilot clinical study in young adults assessing
tolerability, usability and safety. If successful, we will have established technical merit and feasibility for a fully
powered clinical trial to assess efficacy in myopic children.

Public health relevance
Project Narrative This project is relevant to public health because we have defined a new modality for the treatment of myopia progression: indigo light emitting eyewear. This is an exciting treatment strategy because it may enable a highly effective, safe, noninvasive, simple to use, and cost-effective treatment for childhood myopia. We hope that this work represents a turning point in the myopia epidemic with a realistic possibility of treating the many billions of cases of myopia that are predicted to afflict the world population by 2050.